AppalTRuST Career Enhancement Core

ABSTRACT – CAREER ENHANCEMENT CORE
The need for researchers who understand Tobacco Regulatory Science (TRS) and can translate science to
support effective regulatory policies is vital for rural communities which have some of the highest tobacco use
and associated morbidity rates in the nation. The goal of the AppalTRuST Career Enhancement Core (CEC) is
to create a transformative environment that provides mentored, multidisciplinary and immersive career
enhancement experiences to expand and support TRS scholars, with a critical emphasis on the impact of
regulatory policies in rural communities. The CEC will target inquisitive and dedicated scholars with diverse
professional and demographic backgrounds and high potential to become independent TRS researchers.
Building on Center expertise, we will recruit two cohorts of AppalTRuST Scholars, each consisting of two
Faculty Scholars and two Postdoctoral Scholars. These AppalTRuST Scholars will be recruited for a two-year,
non-overlapping experience. Each scholar will work with a mentoring team and participate in multidisciplinary
TRS enrichment activities, enjoying close monitoring of progress toward scientific career independence.
Specifically, AppalTRuST Scholars will receive personalized mentoring and career enhancement experiences
through cohort-building, multidisciplinary TRS enrichment activities including weekly meetings, seminars,
journal clubs and a NIH-modeled grant writing series of workshops. AppalTRuST Scholars will also receive
hands-on experience in TRS research working as part of the research team of one of three AppalTRuST
projects and then developing their own (Scholar-led) TRS pilot project. AppalTRuST Scholars will benefit from
the Cross-TCORS Visiting Scholars Program that will introduce them to scientific domains outside of
AppalTRuST and promote collaborative networks among other TCORS investigators.
CEC will work closely with Project Leads, the Administrative Core, the Community Outreach and Participant
Engagement Core (COPE) and the Biostatistics and Informatics Core (BIC) to ensure AppalTRuST Scholars
have ample resources and opportunities to learn innovative methodologies applied to the rural context. Finally,
CEC will collaborate with the Administrative Core to sponsor an AppalTRuST TRS Seminar Series. Four times
a year, CEC will host these seminars to create collegial and collaborative networks. We will specifically invite
FDA scientists and TCORS faculty and scholars from other TCORS to present and inform AppalTRuST
researchers and the broader TRS community about synergistic opportunities, methodologic advances, and
new research findings across the TCORS community. The seminars will be open to all, as they will be
streamed, recorded, and archived on the AppalTRuST website. Impact. The AppalTRuST Career
Enhancement Core will develop independent scholars who can design and lead rigorous studies that inform
FDA’s tobacco regulatory decision-making in underserved and understudied rural communities, ultimately
reducing tobacco-related morbidity and mortality.